AI algorithm development for cervical cancer screening in low resource settings

PROJECT SUMMARY
Cervical cancer remains a major global health challenge, with over 90% of cases and deaths occurring
in low- and middle-income countries (LMICs). This disparity is primarily due to high prevalence of
HPV infections in many LMICs, limited access to high-quality screening and diagnostic resources, as
well as shortages of trained personnel. Conventional screening methods, including Visual Inspection
with Acetic acid (VIA) and colposcopy, heavily rely on visual assessment, which introduces subjectivity
and variability, especially when conducted by less-experienced clinicians. While colposcopy has been
standard for detecting cervical intraepithelial neoplasia (CIN), it is resource-intensive and demands
trained personnel, making it inaccessible in many low-resource settings.
AI-based Automated Visual Evaluation (AVE) models offer a promising solution, providing consistent,
reproducible classifications that can improve diagnostic reliability. Conventionally, AVE algorithms
have used a single image typically acquired around 1-2 minutes after the application of acetic acid. In
this proposal, we aim to develop advanced AI risk models for cervical cancer screening, using time-
series imaging to capture acetowhitening patterns after acetic acid application on the cervix acquired
on a low-cost device. The model will leverage self-supervised learning (SSL) for precise image
registration across time points and state-of-the-art networks for classification. This approach enhances
the temporal alignment of images, crucial for capturing lesion dynamics. Our model will offer a
comprehensive risk stratification that improves diagnostic accuracy by combining imaging data with
HPV genotyping and AVE.
We will evaluate the model’s performance using datasets representing high- and low-resource devices
and settings. Success in this project will enable consistent, objective, and scalable cervical cancer
screening, with potential impact in low- and middle-income countries, aligning with WHO’s goals for
cervical cancer elimination. Additionally, we will develop and validate novel algorithms for the
analysis of time-series datasets that can be applied to many image analysis problems in oncology.

Public health relevance
PROJECT NARRATIVE This project will develop an AI-driven cervical cancer screening tool that uses temporal imaging data to capture dynamic changes in cervical lesions after acetic acid application. By combining these data with HPV genotyping, the model will enable precise and objective lesion classification, reducing subjectivity and improving diagnostic accuracy. Validated on high-resolution and large-scale datasets from both high- and low-resource settings, this tool aims to enhance accessibility and reliability in cervical cancer screening, supporting WHO's goals for cancer prevention in underserved populations.